Recruitment Core

Project Summary
The recruitment core will serve as the primary means of recruitment of qualifying heart failure
with preserved ejection fraction (HFpEF) patients for the program project grant. Potential
patients will be identified from both a dedicated HFpEF clinic at UT Southwestern as well as
electronic medical record databases that can be screened for specific inpatient hospitalization
codes with over 2,000 unique HFpEF hospitalizations. Screening criteria will focus primarily on
objective documentation of heart failure admission with evidence for volume overload, either by
chest x-ray or exam, in addition to echocardiographic markers of diastolic dysfunction. The
recruitment core will also serve as a point of contact for subjects. Recruitment, scheduling,
follow up of subjects will be done by the core.

Public health relevance
Project Narrative Patients with heart failure with preserved ejection fraction (HFpEF) comprise a diverse group with varying types and severity of co-morbid conditions. The purpose of the recruitment core will be to provide a centralized and rigorous screening mechanism for patients who have a clearly documented hospitalization for HFpEF, impaired left ventricular relaxation and evidence for congestion but also meet none of the exclusion criteria. The recruitment core is essential to the success of the overall program project given the large number of subjects that will be studied in addition to coordinating subject testing and study completion.